Deep Learning Approaches to Risk Stratification in Acute Gastrointestinal Bleeding

PROJECT SUMMARY
Acute gastrointestinal bleeding accounts for over 2.2 million hospital days and 19.2 billion dollars of
medical charges annually. 52% to 55% of patients with acute gastrointestinal bleeding are unnecessarily
hospitalized, leading to wasted resources. Although risk stratification of patients presenting with gastrointestinal
bleeding is recommended, risk-assessment scoring systems are not commonly used in practice, have sub-
optimal performance, may be applied incorrectly, and are not easily updated.
Most current risk scores were designed for use based on the location of the bleeding source: upper or
lower gastrointestinal tract. However, the location of the bleeding source is not always clear at presentation. A
risk score that bases initial assessment on presenting symptoms (e.g., hematemesis, melena, hematochezia) is
more relevant and useful in clinical practice. The electronic health record can be used to identify patients with
acute gastrointestinal bleeding symptoms and extract clinical data to automatically calculate risk scores that are
made available to providers. Machine learning (field of study that gives computers the ability to learn without
being explicitly programmed), particularly deep learning using neural networks (collection of nodes that process
and transmit information), can create electronic health record-based models that perform better than clinical risk
scores for gastrointestinal bleeding and are well-suited for learning from new data.
This proposal will use deep learning tools on electronic health record data to decrease unnecessary
hospitalization in patients with acute gastrointestinal bleeding by identifying low risk patients. The goals are to 1)
Develop and validate an accurate and clinically useful deep learning algorithm for initial risk stratification superior
to existing clinical risk scores 2) Develop and validate a dynamic deep learning tool to model risk over time, and
3) Pilot the best performing algorithms in the electronic health record. Deep learning algorithms will be developed
using a dataset of electronic health record data of 7,000 patients with acute gastrointestinal bleeding from two
academic hospitals in the Yale-New Haven Health System. Validation will be performed on a separate dataset
of patients at Partners Healthcare in Boston, Massachusetts. Neural network approaches will be applied to
patients’ data updated over time to evaluate the trajectory towards requiring transfusion of red blood cells. Finally,
a pilot study will implement the best-performing algorithms in the electronic health record for a 3-month period
to test feasibility of deployment and acceptability to providers and patients. Planned coursework includes deep
learning with biomedical data, risk assessment and longitudinal analysis.
This work has potential to generate cost savings through better integrated risk stratification of patients
presenting with overt gastrointestinal bleeding. To meet the research and educational goals of this proposal, the
mentorship team includes a primary mentor in gastrointestinal bleeding and co-mentors in deep learning,
electronic health record-based clinical trial design of prognostic algorithms, and implementation science.

Public health relevance
PROJECT NARRATIVE The NIH Artificial Intelligence Working Group recently challenged the medical community to train researchers in both healthcare and computer science, proposing that dual training is fundamental to advance artificial intelligence into healthcare and assure these models are safe, interpretable, and effectively integrated into real- world systems. Acute gastrointestinal bleeding is the most common cause of hospitalization for gastrointestinal diseases and many patients are unnecessarily hospitalized. A symptom-based risk assessment tool is more clinically useful than existing scores; this can be developed with deep learning approaches and deployed on the electronic health record to decrease unnecessary and costly hospitalizations.